Molecular mechanisms of mammalian circadian clock function

Abstract
Circadian clocks throughout the body drive rhythmic expression of thousands of genes, resulting in
rhythms in biochemistry, physiology and behavior. Disruption of circadian clocks through genetics or
environmental perturbations such as jet lag or shift-work, can have profound negative consequences
and has been linked to obesity, diabetes, cancer, cardiovascular disease and mental illness. In
particular, circadian clocks exert control over nearly every major metabolic pathway, allowing optimal
utilization of typically cyclic availability of nutrients. Our work is focused generally on
understanding the detailed molecular mechanisms of the mammalian circadian clock
machinery and the mechanisms by which these clocks control rhythmic metabolism. In this
Equipment Supplement request, we seek funds to purchase an integrated plate reader system that
allows determination of fluorescence and luminescence signals both in a typical plate reader fashion
(total signal per well) and also as high quality and high-resolution images due to the integrated
spinning disk confocal microscope. Because of the built-in CO2 incubator with temperature control
and shaker, this piece of equipment will allow us to measure circadian rhythms of gene expression or
metabolites continuously for many days – a requirement for assessing circadian periodicity. Our
studies on the central clock mechanism require careful determination of circadian period length,
amplitude and phase following different experimental manipulations and this reader will allow these
measurements in multi-well format. The sophisticated time-resolved fluorescence and fluorescence
polarization detection will allow the quantitative analysis of protein-protein interactions within the clock
mechanism. In addition, our work on circadian control of metabolism is focused on the control of
NAD(H) and NADP(H) by the circadian NADP(H) phosphatase Nocturnin. Nocturnin is present in two
forms, a mitochondrial form and a cytosolic form that is myristoylated and associates with ER and
other intracellular membranes. In order to determine the role Nocturnin plays in controlling these
metabolites, it is necessary to examine their levels in different intracellular compartments. Because
this plate reader system has spinning disk confocal imaging capabilities, this will allow us to use
NADP(H) fluorescent sensors to follow the flux of NADP(H) and other associated metabolites over
time in different organelles and subcellular locations over time and in response to perturbations in the
clock. These types of experiments are currently impossible since the NADP(H) measurements
cannot be done on a normal confocal microscope and require a spinning disk (we do not have access
to a spinning disk confocal within our department). Furthermore, the length of the experiments and
the need for high throughput require a dedicated instrument. In conclusion, this piece of equipment
will have a major impact on both of the main objectives of our R35-funded work.

Public health relevance
Project Narrative The circadian clock in mammals coordinates many aspects of normal physiology and behavior and when these clocks are disrupted, many health problems, including several types of mental illness, cancer and metabolic problems can occur. This project will investigate how the molecular mechanism of the clock works to keep proper time and drive rhythms in cellular function. This information will be critical for future manipulation of the circadian timing system as a treatment modality for humans suffering from circadian-related health problems.